Molecular and cellular mechanism of Microcephaly

DESCRIPTION (provided by applicant): Autosomal recessive primary microcephaly (MCPH) is a genetically and clinically heterogeneous disease defined by a decrease in head circumference at birth. Patients often have a broad spectrum of neurological problems, including mental retardation, focal or generalized seizures, hyperactivity, and attention deficit disorder. The decrease in brain volume without major architectonic abnormalities most likely stems from a primary defect in neurogenesis and or neuronal migration. Five of eight MCPH genes localize to the centrosome during all or part of the cell cycle. In vitro studies provide evidence that these genes play roles in essential centrosomal functions such as cell cycle regulation. Nonetheless, the mechanism of MCPH in brain development is still poorly understood. The long-term goal of this project is to profile the role of MCPH genes in neocortical development and disease pathogenesis. The objectives are to uncover the molecular and cellular controls of MCPH genes on neurogenesis and to define how centrosomal proteins regulate the mode of division (symmetric or asymmetric), neuronal migration and differentiation. Recent studies from our lab and others have demonstrated that radial glial cells are a major population of neuronal progenitor cells. They divide asymmetrically to self-renew and give rise to cortical neurons. Asymmetric centrosome inheritance is believed to regulate the differential behavior of self-renewing progenitors versus differentiating progeny in the embryonic mouse neocortex. Centrosome defects in Drosophila do not dramatically perturb mitosis in most somatic cells, but the asymmetric division of larval neuroblasts is noticeably disrupted, underscoring the particular significance of centrosome behavior for asymmetric cell division of progenitor cells and determination of daughter cell fate. Furthermore, the centrosome is the primary anchor for microtubules, enabling the differentiating neuron to initiate and extend an axon, a key process of neuron differentiation. Based on these observations, the central hypothesis of this application is that the MCPH genes control neurogenesis, neuronal migration, and differentiation in the developing cortex. Guided by strong preliminary data this hypothesis will be tested by pursuing four specific aims: 1) To determine the molecular and cellular mechanism by which MCPH genes regulate radial glial cell division; 2) To explore the function of MCPH genes in regulating asymmetric inheritance of mother versus daughter centrosomes and daughter cell fate; 3) To define the function of MCPH genes in regulating neuronal migration and differentiation in the developing cortex; and 4) To validate the relevance of findings in the mouse to the pathogenesis of human MCPH using patient induced pluripotent stem (iPS) cells. With innovative approaches including high-temporal time-lapse imaging and molecular genetic techniques, the proposed research will provide new insights into the pathogenesis of MCPH and expand our knowledge of brain development. Moreover, the results of this study may shed light on mechanisms relevant to the etiology of many neurological and psychiatric disorders related to cortical function.

Public health relevance
PUBLIC HEALTH RELEVANCE: This study investigates the molecular and cellular mechanisms of human microcephaly, an important and under-investigated neurodevelopmental disorder. Understanding how microcephaly develops is important not only for a deeper understanding brain development, but also to advance our understanding and potential treatment of a variety of other neurodevelopmental disorders caused through defects in cerebral cortex development including mental retardation, epilepsy, autism, and schizophrenia. PROJECT NARRATIVE This study investigates the molecular and cellular mechanisms of human microcephaly, an important and under-investigated neurodevelopmental disorder. Understanding how microcephaly develops is important not only for a deeper understanding brain development, but also to advance our understanding and potential treatment of a variety of other neurodevelopemntal disorders caused through defects in cerebral cortex development including mental retardation, epilepsy, autism, and schizophrenia. __SpecificAimsTextDelimiter__ Molecular and cellular mechanism of Microcephaly SPECIFIC AIMS Primary autosomal recessive microcephaly (MCPH) is a genetically and clinically heterogeneous disease, in which individuals with MCPH typically exhibit much smaller brain size than normal as well as mild mental retardation, although overall organization of the brain is usually unaffected. Some MCPH patients with neuronal heterotopias, polymicrogyria, or cortical dysplasia have associated neuronal migration defects. Five genes from eight loci can be mutated in this condition. Four of these genes have been shown to encode centrosome-associated proteins (CPAP/HsSAS-4, Cep215/Cdk5Rap2, ASPM, and STIL/SIL), whereas a fifth (MCPH1) encodes a transcription factor linked to DNA damage repair, but this protein also associates with the centrosome. Why do mutations in genes encoding centrosomal proteins produce such specific defects in human brain development? Despite the progress made over the past years, the molecular and cellular mechanisms leading to MCPH remain poorly understood. The long-term goal of this project is to elucidate the mechanisms underlying MCPH in a rodent model and validate them using human patient cells. We hypothesize that neuronal progenitors are particularly sensitive to centrosome defects because the centrosome is essential to maintain proper asymmetric division of radial glial progenitor cells, and is involved in transitioning between distinct phases of migration of daughter cells. This hypothesis is based on the following observations: First, recent studies from our lab and others have convincingly demonstrated that radial glial cells are a major population of neuronal progenitor cells that divide asymmetrically to self-renew and give rise to cortical neurons. Asymmetric centrosome inheritance is believed to regulate the differential behaviors of renewing progenitors and their progeny in the embryonic mouse neocortex. Second, centrosomes exhibit a series of complex behaviors not only during cell division but also during neuronal migration. We found that newly born cortical neurons undergo dramatic shifts in their cytoskeletal structure as they journey to the cortical plate (CP), with both reversals in migration direction and temporary adoption of a multipolar shape. Defects associated with centrosome- and microtubule-associated proteins, such as Lissencephaly-1 (Lis-1), appear to specifically perturb centrosome and nuclear behavior during neuronal migration. Third, the centrosome is the primary anchor for microtubules (MT) enabling the differentiating neuron to initiate and extend an axon, which is a key process of neuron differentiation. We have shown in our preliminary data that centrosome positioning relates to axon initiation and extension. To test our hypothesis, we will use developing rodent cerebral cortex and induced pluripotent (iPS) cells from human patients to pursue the following specific aims: Specific Aim 1: To determine the molecular and cellular mechanism of MCPH genes in regulating radial glial cell division. We will perform loss-of-function studies, e.g. using RNA interference (RNAi) techniques in combination with innovative imaging approaches, such as two-photon laser scanning microscopy (TPLSM) and high temporal resolution time-lapse imaging in organotypic slice cultures, to test whether MCPH genes are required for symmetric and asymmetric cell division of radial glial cells during the peak of neurogenesis. Specific Aim 2: To explore the function of MCPH genes in regulating asymmetric inheritance of mother versus daughter centrosomes during cortical neurogenesis. Centrosome duplication generates one mother centrosome with more mature centrioles and one daughter centrosome with immature centrioles. Previous results suggest that mother and daughter centrosomes are asymmetrically inherited to maintain proper neurogenesis13. Taking advantage of the established fluorescence-based labeling method to distinguish mother versus daughter centrosomes in the embryonic neocortex in vivo, we will perform time-lapse imaging to monitor centrosome behavior with or without MCPH gene RNAi. Specific Aim 3: To define the function of MCPH genes in regulating neuronal migration and differentiation in the developing cortex. We will knockdown MCPH genes in embryonic cerebral cortex and use time-lapse imaging to test the coordination of neuronal migration, nuclear translocation, MT dynamics, centrosome behavior, and axon initiation in differentiating cells generated from radial glial cells. Specific Aim 4: To validate the pathogenesis of MCPH using human induced pluripotent stem (iPS) cells. We plan to directly apply our techniques to study human patient neural progenitor cells derived from iPS cells. This represents a promising strategy to study the mechanisms of genetically inherited disorders of brain development, screen new drug compounds, and develop new therapies. We will generate MCPH iPS cell lines, derive neuronal progenitor cells, and test them using similar assays to our mouse studies to validate our rodent results and better understand the molecular and cellular mechanism of human MCPH genes. These studies will provide critical new insights into the molecular and cellular mechanisms of microcephaly, and will also facilitate the understanding and treatment of a variety of other neurological and neuropsychiatric disorders resulting from defects in cerebral cortical development.